Afferent renal nerves, renal inflammation, and hypertension

Abstract
Hypertension (HTN) is linked to increased sympathetic nervous system activity (SNA) and increased
activity of renal efferent nerves is thought to be important. However, the kidneys are also innervated by renal
afferent nerves, which project to central nervous system circuits that modulate SNA to various peripheral
targets. As such, increased afferent renal nerve activity (ARNA) is also postulated to contribute to increased
SNA and the pathogenesis of HTN. Renal denervation (RDNx) for treatment of HTN in humans is now
possible. However, the mechanisms by which RDNx lowers AP remain unknown. An emerging new theory of
HTN may provide new insights. It is hypothesized that HTN is caused, in part, by a close relationship between
renal nerves, renal inflammation, and HTN. These findings suggest that the antihypertensive response to
RDNx is not due to disruption of neural control of renal function per se, but rather, blockade of the interaction of
immune cells with efferent and afferent renal nerves.
These findings led to the Central Hypothesis of this proposal: DOCA-salt HTN is caused, in part, by
the action of proinflammatory cytokines on afferent renal nerves resulting in neurogenically mediated HTN.
Four Specific Aims will rigorously test this Central Hypothesis. Specific Aim 1: Investigate the
neurophysiological mechanisms by which cytokines modulate ARNA in the DOCA-salt rat. Specific Aim 2:
Define the anatomical substrates responsible for modulation of ARNA by immune mediators in DOCA-salt rats
and mice. Specific Aim 3: Correlate the hemodynamic mechanisms mediating the anti-hypertensive response
to ablation and pharmacological blockade of ARNA in DOCA-salt HTN, to urinary biomarkers of renal
inflammation. Specific Aim 4: Employ a novel GCaMP3 mouse ex vivo renal slice preparation to identify
molecular targets mediating cytokine modulation of afferent renal nerves in normal and DOCA-salt mice.
Identification of the mechanisms by which immune cells interact with renal afferent nerves in HTN will also
benefit understanding other renal inflammatory diseases with elevated SNA such as chronic renal failure.

Public health relevance
Public Health Relevance Hypertension (HTN) is the single leading cause of morbidity and mortality in the United States. The proposed research will aid in the development of new therapies that target the nerves to the kidney to reverse inflammation and HTN.